Confocal illumination system to apply optogenetic tools for hematopoietic stem cell biology with single cell resolution

Project Summary:
Molecular genetic tools using DNA recombinases, such as Cre and Flp, and nucleases, Cas9, have been applied
to address various biological questions. The genetic technologies allow us to manipulate gene expression and
engineer genome to uncover the molecular mechanism underlying a variety of biological activities such as
cellular proliferation and differentiation. However, precise spatiotemporal control is still limited though using the
existing tools. In this project, we will develop a new set of optogenetic tools with single cell resolution to address
this issue, using a new confocal module. Taking advantage of the confocal module-mediated illumination to live
cells, we will validate and optimize our optogenetic tool uses in mammalian primary cells such as hematopoietic
stem cells. Also, our proposed novel genetic technologies will be widely applicable to various research fields
beyond hematopoiesis to address a variety of biological questions.

Public health relevance
Public Narrative: This project will develop and apply novel genetic technology to understand blood cell biology. Our research will provide a new insight to understanding how blood cells are generated and regulated in mammals.